Correlates of protective immunity to HCV and rational vaccine design: Project 3

Hepatitis C virus (HCV) continues to infect ~71 million people worldwide with an estimated 1.5 to 2 million new
infections each year. A complete eradication of HCV infection warrants development of an effective vaccine that
can rapidly induce a durable anti-viral immunity and prevent infection. Evidence from spontaneous controllers
suggests that a broad and durable HCV-specific CD4 and CD8 T cell responses are critical for effective control
of HCV infection. In addition, a protective role for neutralizing antibody against viral glycoproteins E1&E2 has
also been implicated. Furthermore, it is critical generate anti-viral immunity in the liver (the primary site of virus
replication). Thus, the primary goal of this proposal is to develop a vaccination strategy using DNA, modified
vaccinia Ankara (MVA), and protein-based vaccines that will generate a robust and broad HCV specific T and B
cell responses in blood and liver against multiple HCV proteins. We hypothesize that induction of a strong, broad,
and persistent T cell response against HCV antigens in the blood and liver combined with induction of strong
neutralizing antibody response will provide protection against HCV infection and different combinations of
DNA/MVA/protein vaccination can be harnessed to achieve the desired protective immunity. We propose to
achieve these objectives using 3 specific aims. In Aim 1 we will construct and characterize DNA and MVA
vaccines expressing HCV core, NS3-NS5 and E1E2 proteins. In Aim 2 we will optimize the DNA/MVA vaccine
modality for inducing strong T cell and antibody responses. The optimizations will include testing the E1E2 in
two forms either presented on the virus-like particle (VLP) or secreted. In addition, we will test the influence of
CD40L adjuvant on cellular and humoral immunity. In Aim 3 we will optimize E1E2 protein boosts for DNA/MVA
vaccine for further enhancing the antibody responses. By completion of these studies we hope generate an
optimal vaccine against HCV that induces strong T cell and neutralizing antibody responses.

Public health relevance
Hepatitis C virus (HCV) continues to infect ~71 million people worldwide with an estimated 1.5 to 2 million new infections each year. A complete eradication of HCV infection warrants development of an effective vaccine that can rapidly induce a durable anti-viral immunity and prevent infection. The overall goal of this Project 3 is to develop an effective prophylactic vaccine against HCV.